RIP1/RIP3-Calpain-Stat3 and NF-kappa B pathways in AML pathogenesis and treatment

Both NF-κB and Stat3 are abnormally activated in leukemic blasts and are implicated in drug-resistance
and poor prognosis, suggesting they could be potential targets for therapy. We found that inactivation of both
NF-κB and Stat3 signaling pathways synergistically represses self-renewal and drug-resistance in leukemia stem
cells (LSCs), suggesting a compensatory role for these two pathways in the pathogenesis of leukemia.
Stat3α and Stat3β are two major splicing isoforms. Active Stat3α promotes tumor growth by regulating
target gene expression (functions as a transcription factor) and controlling mitochondrial production of ATP and
ROS (functions as a regulator of the electron transport chain), while Stat3β lacks a transactivation domain and
functions as a dominant-negative to Stat3α. All currently used inhibitors of Stat3 only repress its transcriptional
activity without taking consideration of its mitochondrial activity, which might explain why these inhibitors failed
to repress leukemia in patients. It was reported that induction of the switch from Stat3α to Stat3β provides a
better tumor repressive effect than inhibition of both isoforms. We found that we can induce such a switch by
inhibiting the serine/threonine-protein kinases receptor-interacting protein kinase 1 (Rip1) and Rip3.
Rip3 and NF-κB are parallel downstream signaling pathways of Rip1, mediating cytokine-induced kinase-
dependent and -independent activities of Rip1. We found that a moderate level of activation of Rip1-Rip3 kinase
signaling exists in acute myeloid leukemia (AML) cells with MLL1-rearrangement (MLL-r) or NPM1 mutation
(NPM1c+). Rip1-Rip3 signaling plays distinct roles in normal hematopoietic stem/progenitor cells（HSPCs）and
AML cells. In HSPCs, Rip1-Rip3 signaling mediates TNFα and IL1β-induced necroptosis, while in AML cells, the
moderate activation of such signaling is required for maintaining the levels of Stat3α by inhibition of calpain
(CAPN), a family of proteolytic enzymes. CAPN reduces Stat3α and enhances Stat3β by specifically cleaving
Stat3α protein and also SFRS5, a splice regulator for alternative splicing for Stat3α. Inhibition of Rip1-Rip3 kinase
signaling results in depletion of Stat3α and an increase of Stat3β. Our study suggested that, as with co-inhibition
of Stat3 and NF-κB, co-inhibition of Rip1-Rip3 signaling and NF-κB also compromises self-renewal of LSCs and
sensitizes AML to standard chemotherapy. We want to test our novel combination treatment regimen in primary
human AML cells using xenograft models. We also intend to elucidate the molecular mechanisms by which Stat3
and NF-κB regulate self-renewal and drug-resistance in LSCs as well as the molecular mechanism by which
Rip3 signaling regulates CAPN-dependent Stat3 isoform switch.
The expected results of this study will allow us to determine whether combinations of currently known
inhibitors of Rip1/Rip3 and NF-kB signaling could improve treatment for MLL-r and NPM1c+ AML when combined
with standard chemotherapy. The mechanistic studies will provide detailed information allowing us to more
effectively target the Rip3-CAPN-Stat3 pathway to treat AML.

Public health relevance
Inflammatory cytokine-stimulated Rip1-Rip3 kinase pathway induces necrosis in normal tissue cells but promotes the growth and drug-resistance in leukemia cells. Co-inhibition of the Rip1-Rip3 pathway and NF-κB, a well-known survival factor for leukemia stem cells, sensitizes leukemic cells to standard chemotherapy and at the same time provides protection to normal tissue cells. We want to evaluate such novel combination treatments in human primary leukemic cells using xenograft animal models.